Extracellular Vesicles as Biomarkers and Therapeutic Targets for Atherosclerotic Cardiovascular Disease in Persons Living with HIV

Project Summary: Despite antiretroviral therapy (ART), people living with HIV (PLWH) have a two-fold
increased risk of cardiovascular disease (CVD) compared with the general population. While persistent
systemic inflammation and immune activation appear to predict this risk, it has been challenging to identify the
pathophysiologic pathways that can be targeted to reduce inflammation and cardiovascular risk in treated HIV
infection. Extracellular vesicles (EVs) play a significant role in regulating pathophysiologic pathways like
inflammation and angiogenesis, and they are implicated in key aspects of heart disease. To date, limited data
exist on the molecular mechanisms underlying the effect of EVs on atherosclerosis progression, leaving open
the question of how EVs might impact the resolution of inflammation to influence CVD risk in HIV. This
proposal is innovative in that it will employ high-throughput testing platforms for characterizing EVs and their
cargo on longitudinal samples from well-characterized cohorts of persons with HIV and CVD and will utilize a
novel mouse model of HIV atherosclerosis and cutting-edge in vitro models to identify and validate novel
inflammatory mediators carried by EVs and provide potential novel targets for intervention. In Aim 1, we will
test the hypothesis that 1) Immunologically active EVs derived from HIV+ adults on ART will carry pro-
inflammatory mediators that will be associated with carotid artery intima-media thickness progression; and 2)
EVs from HIV+ adults with higher CVD risk will carry a unique miRNA signature and will be associated with a
specific inflammatory pathway (e.g. NLRP3 inflammasome signaling/caspase-1 activation). In Aim 2, we will
develop a novel accelerated atherosclerosis mouse model associated with HIV infection to test the hypothesis
that 1) Systemic administration of EVs derived from HIV-1 Tg26/ApoE−/− mice will more strongly induce
production of proinflammatory mediators when infused into recipient mice and will transfer molecules that alter
exosomal miRNA expression in recipient cells; 2) DNA-containing EVs from HIV-1 Tg26/ApoE−/−mice will
induce epigenetic changes in recipient cells; and 3) the administration of EVs derived from VX-765 or
MCC950-treated atherosclerotic mice will produce circulating EVs that lack the ability to affect the exosomal
miRNA expression in recipient cells. In Aim 3, we will test the hypothesis that 1) EVs from those with high CVD
risk will directly cause cardiomyocyte and endothelial cell dysfunction and promote increased cell death
compared to controls; 2) Caspase inhibitors (caspase-1/inflammasome inhibition) will mitigate apoptosis in
cardiomyocytes and endothelial cells mediated by EVs derived from those with high CVD risk; and 3) EV
signaling will be dependent on EV RNA content for delivery of a pro-inflammatory signal. We also will focus on
the development of genome-wide CRISPR screens to identify the causal variants, genes, and molecular
mechanisms on cardiac cell function. We aim to create a new paradigm for discovery of novel EV-based
interactions that can be targeted to prevent immune activation and inflammation that persists in PLWH.

Public health relevance
Project Narrative As HIV-infected individuals age, they experience non-AIDS, inflammation-related illnesses, such as cardiovascular disease (CVD), even when the virus is suppressed with antiretroviral therapy. This proposal will yield novel integrated and innovative approaches in the emerging field of extracellular vesicles (EVs) and HIV- associated atherosclerosis to reveal a novel measure of immune/inflammatory responses for discovering potential predictor biomarkers and will make unique contributions to the deeper understanding of how EVs and their cargo impact the resolution of inflammation to influence CVD risk in HIV in a mechanistic manner. The idea is that, if extracellular vesicles are altered, then by understanding exactly how they are altered, we will lay the groundwork for developing novel therapeutic strategies to reduce HIV-associated chronic inflammation, and lifelong co-morbidities.